Electron Spin Resonance Microfluidics as a new tool in chemical single cell population analysis

ABSTRACT
Single-cell analysis is a transformative capability in modern biological and medical research that enables
capturing the heterogeneity between cells within an entire cell population. Single-cell analysis can inspect
biological, chemical, and physicochemical parameters at the single-cell level. While there are numerous
analytical approaches to single-cell analysis, magnetic resonance and especially electron spin resonance (ESR),
is yet to contribute to this field, mostly because of a sensitivity issue and the lack of appropriate bio-stable
intracellular spin probes. This proposal aims to develop a highly sensitive ESR-based flow cytometry technology
(instrumentation and molecular spin-probes) that enables single-cell analysis of chemical and physicochemical
parameters. The current project focuses on the simultaneous measurement of pO2 and microviscosity at the
single-cell level to develop and demonstrate the concept. However, the technology can be applied to assess
other parameters in the future, such as microviscosity, pH, oxygen concentration, redox status, and glutathione.
We will achieve our goal by the following three specific aims. In SA1, we will synthesize and characterize
intracellular biostable trityl spin probes sensitive to the oxygen concentration and microviscosity. In SA2, we will
develop a compact, highly sensitive ESR surface resonator embedded in a cell microfluidic device to measure a
continuous flow of single cells. Finally, in SA3, we will validate our technology with the single-cell measurement
for a population of a few hundred cells of a cancer cell line. The completion of this R21 project will expand the
current capability in single-cell analysis, allowing assessing multiple parameters that cannot be fully
characterized by the currently available techniques with significant new applications downstream.

Public health relevance
PROJECT NARRATIVE This proposal aims to develop a new Electron Paramagnetic Resonance (EPR)-based methodology that enables fast and continuous analysis of cellular chemical and physical properties at a single-cell level.